Adaptation of an Evidence-based Family Program for Obesity Prevention in Health Care Context: Testing Outcomes and Mechanisms with First-time Military Parents and their Infants

PROJECT SUMMARY
The proposed study will test the efficacy of a family-focused preventive intervention in improving
healthy lifestyles among first-time parents in military families and reducing obesity risk among their
infants. The ultimate goals of the intervention are to reduce rapid infant weight gain, an early indicator of
future obesity risk, and new mothers’ postpartum weight retention, a contributor to intergenerational
obesity transmission. In three trials, the Family Foundations (FF) program—consisting of a series of
classes delivered in a health care context before and after birth—has demonstrated robust, replicated,
long-term impact on family relationships (coparenting, parenting, family violence) and on parent and
child internalizing and externalizing problems through at least 7 years after birth. The theoretical “active
ingredient” of FF, validated by mediation analysis of program impact, is support for the development of a
cohesive, supportive coparenting relationship. In the proposed study, we will test an adapted version of
FF (termed “FF+”) that broadens the coparenting approach to help parents’ cooperate and support each
other in establishing and maintaining healthy family lifestyle behaviors and specific health-promoting
parenting strategies. We propose to test FF+ in military families, who experience overweight/obesity at
levels similar to their civilian counterparts. Recruitment and intervention will be conducted within
obstetric clinics in three Military Health System hospitals. Recruitment, intervention delivery, data
collection, and follow-up will be facilitated by the military context.
Aim 1. To assess the efficacy of the adapted FF+ program in a randomized trial. 250 families will be
randomized to FF+ or control conditions. Data will be collected in home visits at pre-test during
pregnancy, post-test at 6 months postpartum, and follow-up at 12 months postpartum, with additional data
obtained from electronic health records. Aim 2. To test mediation pathways. Aim 3. To assess whether
baseline parent characteristics, program delivery fidelity, or participant engagement moderate program
effects on outcomes.

Public health relevance
PROJECT NARRATIVE The proposed study will test the efficacy of a family-focused preventive intervention in improving healthy lifestyles among first-time parents in military families and reducing obesity risk among their infants. We propose to test this innovative approach in the context of the Military Health System (MHS), within a research network of military family medicine physicians, for several reasons. Recruitment will be conducted by embedded clinical staff from the network in the primary care clinics, and follow-up will be facilitated by the tracking providing by the MHS.